ADMINISTRATIVE

The primary goal of this core is to provide an administrative structure that will assure integration of all projects and scientific cores. This structure will maximize scientific progress made by the group by providing a structure whereby advances made in individual projects can be rapidly exploited by all of the projects through refinement of hypotheses and experimental design. The specific goals of this core are to: 1) facilitate communication among Program Project Investigators and Core Directors through regular meetings; 2) assume responsibility for preparation of documents related to Program Project activities;3) organize and conduct annual meetings of Program Project participants with the internal and external Scientific Advisory Groups;and 4) conduct fiscal oversight of the projects and cores through regular meetings with the appropriate individuals within Mayo Clinic Research Administration.